Microscopy Shared Resource

MICROSCOPY SHARED RESOURCE – PROJECT SUMMARY/ABSTRACT
The Microscopy Shared Resource was developed in concert with the initiation of the Cold Spring Harbor
Laboratory (CSHL) Cancer Center in 1986, and, led by Faculty Head David Spector, Ph.D., has been
continuously serving Cancer Center members since that time. The Microscopy Shared Resource is widely used;
over the last funding period, it was used by 68% of the Cancer Center membership (26 members). The state-of-
the-art Microscopy Shared Resource provides Cancer Center members with access to standard and advanced
microscopy systems and sophisticated technical expertise. Among the types of services rendered are wide-field
fluorescence microscopy, deconvolution microscopy, laser-scanning confocal and spinning-disk confocal
microscopy, live-cell imaging, and structured-illumination super-resolution microscopy. In addition to providing
users with access to the microscopes, the Microscopy Shared Resource also provides technical assistance in
preparing cells or tissues for immunofluorescence microscopy, transmission electron microscopy or
immunoelectron microscopy, DNA spreading, and evaluation of subcellular-fractionation procedures by negative
staining or thin sectioning.
The Microscopy Shared Resource offers assistance and training with advanced image-analysis solutions.
Cancer Center members have access to several image-analysis software packages, remotely or in the Shared
Resource. Cancer Center members may be trained for unassisted use of the majority of the microscopes, while
full-service assistance by facility staff is also available for qualitative and quantitative microscopy.
Without the Microscopy Shared Resource, it would be extremely difficult for individual investigators to have
access to the sophisticated instrumentation and these specialized services, which are critical to their research
programs. In addition, the Microscopy Shared Resource serves as a focal point where users can interact, learn
about new imaging technologies, exchange and discuss the availability of new fluorescent proteins/probes or
antibodies, and gain insight into novel imaging approaches that will advance their science. In summary, the
Microscopy Shared Resource provides the user group with a full complement of state-of-the-art instrumentation
and advanced technical support to help accelerate cancer research and discovery.

Public health relevance
MICROSCOPY SHARED RESOURCE – PROJECT NARRATIVE Not required per PAR-20-043